Community Partners Component

Maternal American Indian Rural Community Health Research Center of Excellence | M.A.R.C.H.
PROJECT SUMMARY – COMMUNITY PARTNERSHIP COMPONENT
The purpose of the Maternal American Indian Rural Community Health Research Center of Excellence (MARCH)
Community Partnership component serves as the central lynchpin and administrative home to connect center
activities with the vast network of partners. The MARCH Community Partnership component has several avenues at
various levels of the socioecological systems model to engage community members and agencies to achieve mutual
goals to improve maternal health and well-being. The key elements of the MARCH Community Partnership component
include 1) providing administrative leadership and oversight to ensure all MARCH milestones and goals are met in a
timely fashion with continued active involvement and engagement across community partners and MARCH; 2)
creating and promoting specific communication mechanisms about MARCH activities, opportunities and study findings
to all partners, the MARCH research community, and external stakeholders positioned to influence clinical practice
and policy; and, 3) embed a comprehensive evaluation plan within all MARCH components and research project.